Orbitofrontal Cortex - Ventral Tegmental Area Projection Neurons: Mapping Function to an Anatomically and Molecularly Distinct Neural Subpopulation

PROJECT SUMMARY/ABSTRACT
Poor decision-making is both a cause and a consequence of addiction. Though dysfunction of the orbitofrontal
cortex (OFC) is thought to underlie decision-making deficits in addicts, a circuit-based mechanism has not been
identified due to overwhelming functional heterogeneity. Preliminary retrograde labelling experiments suggest
that individual OFC projection neurons selectively target subcortical structures, but it is unknown if this
anatomical separation mirrors a functional division-of-labor and a fundamental subcortical sorting principle.
Integrating state-of-the-art techniques from functional genetics and electrophysiology, the objective of this
proposal is to directly map a decision-making variable to a distinct cell-type in the OFC. The proposed aims will
test the central hypothesis that that there is a division-of-labor between different OFC output neurons and more
specifically, that OFC-to-VTA projection neurons represent a distinct output tract that selectively routes choice
value. In Aim 1, I will determine the target selectivity of OFC-to-VTA projection neurons at a single neuron
resolution. In Aim 2, I will determine if OFC-VTA projection neurons represent a genetically-distinct cell-type. In
Aim 3, I will provide cell-type specific recordings in rats performing a rich, perceptual decision-making task and
determine the role of OFC-VTA projection neurons in supporting choice behavior. These studies contribute to a
mechanistic understanding of how decisions are computed and potentially, reveal an overarching, fundamental
principle that governs cortical-subcortical information distribution in the OFC. The proposed studies lay the
foundation for the identification of cell-type specific dysfunction in addiction and in future, the development of
more effective, circuit-based therapies. Ultimately, this proposal serves to prepare me for a career as an
independent physician-scientist. I will obtain a unique and multi-disciplinary skill-set that, in the future, will enable
me to better bridge the gap between experimental neuroscience and clinical practice.

Public health relevance
PROJECT NARRATIVE Long-lasting decision-making deficits in addicts represent a serious barrier to treatment adherence and long- term sobriety. A fundamental organizational principle that might sift through the overwhelming cellular heterogeneity and identify specific cell-types that might be therapeutically targeted is currently lacking. This proposal aims to delineate the circuit-level architecture of the orbitofrontal cortex (OFC) and define its distinct subcortically targeting output neurons as distinct streams of information, elucidating a fundamental principle of information routing.